A new model for understanding a brain tumor epigenetic driver

ABSTRACT
Diffuse intrinsic pontine glioma (DIPG) is an aggressive tumor of young children that infiltrates the brainstem,
and although radiation therapy can slow tumor growth, most children with DIPG die within two years of diagnosis.
To develop more effective therapies, it is necessary to understand the molecular and cellular mechanisms that
drive DIPG. Approximately 80% of DIPG tumors carry a point mutation in one of the histone 3 (H3) genes that
causes a substitution of lysine 27 for methionine (H3K27M). Expression of H3K27M mutant protein is an
oncogenic driver, increasing cell proliferation, and causes aberrant gene expression. Chromatin is a dynamic
polymer of DNA and histone proteins, and the trimethylation of H3 lysine 27 (H3K27-me3) correlates with
transcriptional repression. H3K27-me3 is catalyzed by EZH2, and the H3K27M mutant histone protein inhibits
EZH2 activity, causing widespread loss of H3K27-me3 across the genome. However, this loss of H3K27-me3
does not closely correlate with transcriptional de-repression. For example, in cells expressing the H3K27M
mutation, only about 4% of the genes that lose H3K27-me3 increase their expression. Does H3K27M instead
affect gene expression by altering “higher-order” aspects of genome organization, such as the interaction of
chromatin with specific nuclear “compartments?” The lamina of the inner nuclear membrane is a transcriptionally
repressive nuclear compartment. Lamina associated domains (LADs) are large, specific genomic regions
located at the nuclear periphery, and genes within LADs exhibit low transcriptional activity. H3K27-me3 is highly
enriched at the “borders” between LADs and non-LAD genomic regions, suggesting a role for this chromatin
modification in regulating this aspect of higher-order genome organization. In Preliminary Studies, we have
mapped LADs in DIPG cells that carry the H3K27M mutation, finding that the LAD architecture is uniquely
disrupted as compared to other types of cancer and normal cells. Given our biochemical understanding of
H3K27M mutant protein, the function of EZH2, and our knowledge of LAD border structure, we propose
experiments that test the following hypothesis: By inhibiting EZH2 and causing genome-wide changes in
H3K27-me3 levels, the H3K27M mutant protein disrupts normal LAD structures, and that such disruption of
nuclear compartment-associated genome organization underlies the abnormal gene expression of DIPG. This
work challenges the current understanding of H3K27M oncogenic effects. Instead of building upon the current
model that explains H3K27M oncogenic function at the level of local chromatin state changes, results obtained
test a new paradigm, that H3K27M causes a much larger-scale change to the organization of the genome in the
nucleus. Mutations in histone proteins such as H3K27M represent an emerging class of oncogenic drivers in a
wide diversity of cancer, both rare and prevalent. Thus, understanding how H3K27M affects nuclear
compartment-associated genome organization may provide foundational knowledge to the broader class of
oncohistone mutations.

Public health relevance
PROJECT NARRATIVE Diffuse intrinsic pontine glioma (DIPG) is a lethal type of pediatric brain tumor, and DIPG tumor cells express a mutant protein called H3K27M. H3K27M represents an emerging class of mutations that promote the growth of specific types of brain tumors. Thus, understanding the cancer-promoting effects of H3K27M can provide foundational knowledge to this broader class of oncogenic mutations.